Detecting synergistic effects of pharmacological and non-pharmacological interventions for AD/ADRD

SUMMARY
Alzheimer's disease (AD) and associated dementia (ADRD) are multifaceted conditions influenced by a diverse
array of genetic and environmental contributors, affecting a significant population in the United States. Despite
extensive investigation, the collective impact of pharmacological interventions (PI) and non-pharmacological
interventions (NPI) on ADRD remains largely underexplored. Consequently, the principal objective of the main
award is to devise translational informatics strategies to compile, standardize, and unveil the influence of PI and
NPI candidates on AD/ADRD employing biomedical literature, supplemented by validation through animal
models. This proposed administrative supplement project intends to augment the scope of our primary project
by harnessing avant-garde technologies to tackle intricate scientific challenges using cloud computing resources.
Our specific aims are: Aim 1. Extract relevant information from diverse modalities using LLMs for PANIA-KG,
and maintain the data on cloud storage. Aim 2. Constructing an LLM-based RAG for PANIA-KG and deploying
a user-friendly intelligent visual interface on Cloud Service.

Public health relevance
Narrative Alzheimer's disease (AD) and related dementias are complex conditions influenced by genetic and environmental factors, with current research lacking computational tools to systematically analyze pharmacological and non-pharmacological interventions (PI and NPI). Our parent project aims to develop informatics strategies to gather and standardize data on these interventions using various data sources, validated through animal models. The administrative supplemental project will focus on developing large language models to create the knowledge graph (PANIA-KG) and interactive applications for using the PANIA- KG by utilizing advanced technologies like cloud computing, cloud storage.